Patient-centered Quality Measurement for Opioid Use Disorder

BACKGROUND: Delivery of evidence-based treatment for opioid use disorder (OUD)—especially medication
treatment (MOUD)—reduces morbidity and mortality and is the bedrock of OUD care. Yet fewer than half of
Veterans with OUD receive MOUD, and up to half who initiate treatment do not remain in treatment after 12
months. Access to treatment is a barrier that many interventions have addressed in recent years; however,
there is also evidence that many Veterans with access to treatment may not engage in care (i.e., seek care,
pursue treatment, adhere to treatment plan, follow up with a provider). Patient-centered care is a tenet of care
quality that can improve patient engagement but has not been measured for OUD care. Gaps identified in
patient-centered care for OUD could represent targets for quality improvement interventions that increase
patient engagement, improve treatment delivery, and reduce mortality. My study objective is to develop and
implement a quality measurement and quality improvement strategy that will improve patient-centered care for
Veterans with OUD. My long-term goal is to become an independent VA clinician-investigator with a focus on
improving healthcare access and quality for Veterans with OUD and other substance use disorders (SUDs).
SIGNIFICANCE/IMPACT: OUD prevalence, morbidity, and mortality among Veterans are disproportionate to
the general US population. To address this disparity, VA has expanded treatment access, but overall
engagement among affected Veterans remains low. The extent to which patient engagement is affected by the
quality of patient-centered care is not established because there are few quality measures for OUD, and most
are not patient-centric. Instead, current measures may disincentivize patient-centered care by measuring
aspects of care outside the full control of the provider (e.g., treatment initiation, adherence, and retention) and
favor treating patients already committed to recommended care over those who are not. VA has a track record
as a leader in both patient-centered care and SUD care that spans decades, making this study optimal for VA.
INNOVATION: This CDA-2 will measure the quality of patient-centered care through audio-recorded patient
visits (patient-collected audio). It will also incorporate the patient voice in defining a provider feedback
intervention to improve patient-centered care, through direct elicitation of patient preferences and partnership
with a Veteran Advisory Panel.
SPECIFIC AIMS: There are three aims in this study: (1) To assess performance of VA OUD providers on
measures of patient-centered care and the association of patient-centered care performance with patient
engagement; (2) To identify preferences, needs, and values of Veterans with OUD that impact their willingness
to engage in care; and (3) To develop and implement a provider performance audit and feedback intervention
based on patient-centered measures of OUD care quality.
METHODOLOGY: I will use patient-collected audio recordings of 300 OUD-related clinical visits to assess
provider performance on five validated measures of patient-centered care at two VA facilities, followed by chart
review to compare the extent of patient-centered care received to six measures of engagement six months
after initial assessment. Next, I will (a) interview Veterans with OUD regarding their preferences, needs, and
values related to OUD care and (b) survey Veterans with OUD using best-worst scaling to identify preference-
ordered themes that are perceived as likely to increase engagement in care. I will then bring together VA
stakeholders (patients, providers, leaders) using a nominal group technique to (a) review provider performance
and patient preferences related to patient-centered care and patient engagement and (b) develop and
implement a provider feedback intervention to improve patient-centered care for OUD at one VA.
NEXT STEPS/IMPLEMENTATION: I will work with key stakeholders, including Veterans, clinicians, and VA
operational partners, to expand this quality measurement and implementation strategy across VA.

Public health relevance
Veterans with opioid dependence or addiction (known as opioid use disorder or OUD) reduce their risk of adverse health outcomes, overdose, and death when they receive evidence-based treatments, including medication treatment (MOUD). VA has been successful in improving access to these treatments for all Veterans. However, many Veterans with OUD are not engaged in care (e.g., do not receive available treatment or discontinue treatment prematurely). Providing patient-centered care, or care that is specific to patient preferences, needs, and values of each Veteran, can improve engagement in care, but the extent to which this occurs in VA is not known. VA is committed to delivering patient-centered care. Key to fulfilling that commitment is Veteran patients’ involvement in defining how care should be delivered to meet their needs and in developing appropriate measures of patient-centered care to provide meaningful feedback to OUD clinicians and improve clinical performance. This study aims to improve patient-centered care for Veterans with OUD.